METS-Sleep: Sleep timing, gut microbiota and cardiometabolic risk across the Epidemiologic Transition

PROJECT SUMMARY
Late chronotype has been associated with gut dysbiosis and increased cardiometabolic (CM) risk, yet the causal
mechanisms are unknown. Existing studies are limited by contradictory findings, small sample sizes, imprecise
measurements of sleep and CM risk, as well as lack of detailed measures of dietary intake and other
environmental exposures/mediators. The objective of this study is to compare sleep patterns, gut microbiota,
lifestyle behaviors, and risk for CM disease in individuals from 5 distinct African-origin populations. The second
objective is to humanize mice with gut microbiota from study participants identified by chronotype (early vs. late)
in each of the 5 cohorts and challenge the mice to high fat feeding in order to confirm the transferability of the
late chronotype impact on gut dysbiosis. The proposed study will investigate sleep timing associations with the
gut microbiota and CM risk, including elevated waist circumference, elevated fasting glucose,
hypertriglyceridemia, elevated blood pressure, and low HDL, in existing cohorts with significant lifestyle diversity
(i.e., diet and physical activity), who have been followed prospectively since 2010. The associations identified
will guide fecal microbiota transplant experiments in mice using stool from participants identified by chronotype,
and exposed to a 20-week high fat diet challenge to confirm the associations between sleep timing, gut
microbiota and CM risk factors. Participants are currently enrolled in METS-Microbiome (R01-DK111848), an
ongoing prospective cohort study leveraging an existing cohort of five diverse, well-defined populations from the
Modeling the Epidemiologic Transition Study (METS, R01-DK080763). METS is comprised of a cohort of 2,500
adults, living in 5 distinctly different environments: Ghana, South Africa, Jamaica, Seychelles and the US. Our
preliminary data from the METS cohorts suggest that gut microbiota diversity is negatively related to CM risk and
sleep disruption. In addition to yearly health measurements, including anthropometrics, blood pressure and CM
risk measures, we propose to measure sleep timing using actigraphy in 1000 participants (N=200 from each site)
currently enrolled in METS-Microbiome. We will use a causal mediation analysis to identify the direct and indirect
effects of sleep timing on the gut microbiota. We will thus capitalize upon existing, extensively described cohorts
of adults from geographically dispersed populations, resulting in significant variation in environmental covariates.
The proposed study will substantially advance our understanding of sleep timing associations with the gut
microbiota and CM risk, which is critical given modern 24/7 “on-demand” societies requiring both night and early
morning work hours.

Public health relevance
PROJECT NARRATIVE Urbanization and economic development is associated with an increased mis-timed sleep relative to the ~24-h circadian clock (“circadian misalignment”); as modern 24-7 “on-demand” societies require night and early morning work hours. Those presenting with more circadian misalignment have increased cardiometabolic risk. A new factor, the gut microbiota have also been associated with increased cardiometabolic risk. The proposed research here will explore mechanisms through which circadian misalignment impacts the gut microbiota, increasing the risk for cardiometabolic disease. The study utilizes a prospective longitudinal design, in a well- described cohort of adults of African origin, living at different stages of social and economic development. The goal of this study is to compare adults from 5 diverse sites with respect to their sleep and meal timing, gut microbiota, lifestyle behaviors, and risk for CM disease. A second objective is to humanize mice with gut microbiota from participants identified by sleep timing in each of the 5 cohorts, and challenge them to high fat feeding.